Reduced DNA Repair Capacity Leads to Increased Risk of Uterine Fibroids (UFs) in African Americans

Abstract
Uterine Fibroids (UFs, AKA: leiomyoma) are the most important benign neoplastic threat to women's health. They are the
most common cause of hysterectomy causing untold personal consequences and hundreds of billions of health care dollars
worldwide. Currently, there is no long term effective FDA-approved medical treatment available, and surgery is the
mainstay. The etiology of UFs is not fully understood. In this regard, we and others have recently reported that somatic
mutations in the gene encoding the transcriptional Mediator subunit MED12 are found to occur at a high frequency (~85%)
in UFs. UFs likely originate when a Med12 mutation occurs in a myometrial stem cell converting it into a tumor-forming
stem cell leading to a clonal fibroid lesion. UFs do not affect all races equally. Increased prevalence of UFs in African-
American (AA) women has been consistently observed for >120 years. The molecular attributes behind UFs ethnic disparity
are not fully realized; however, a growing body of literature implicates unfavorable early life environmental exposures as
potentially important contributors. Environmental exposures during sensitive windows of development can reprogram
normal physiological responses and alter disease susceptibility later in adult life. In the Eker UF rat model, we have recently
reported in PNAS that early life exposure to environmental xeno-estrogens increased tumor-suppressor-gene penetrance in
adult rats up to ~100%. Compelling preliminary data from our laboratory further identified that such exposure exerts two
alterations in exposed rat myometrium: (1) permanently expands myometrial stem cell compartment and, (2) decreases
DNA damage repair capacity. Quantitative PrimePCR array indicated that several DNA damage repair genes are
significantly down regulated including RAD50, Sirt, and TP53 in myometrium from rats neonatally exposed to
xenoestrogens. Importantly, in the human equivalent, we have encountered similar observations. MyoF (high risk
myometrium from fibroid uteri) exhibited expanded myometrial stem cell compartment as well as a decrease in DNA
damage repair capacity as compared to MyoN (normal myometrium from healthy fibroid-free uteri). This was significantly
more noticeable in AA women. Importantly, key DNA repair genes of RAD50, Sirt1, MLH1, and MLH3 were markedly
decreased in MyoF vs MyoN. Our central Hypothesis: Early life exposure, during the sensitive period of uterine
development, to environmental toxicants, which is more prevalent in AA, permanently expands the number of myometrial
stem cells as well as permanently reprograms and attenuates key DNA damage repair genes leading to reduced myometrial
DNA damage repair capacity. Chronic reduction in DNA repair capacity eventually leads to the emergence of mutations
such as Med12 in myometrial stem cells converting them into fibroid tumor-forming stem cells and subsequently leads to
the development of UFs. We will address this hypothesis using the following three specific aims; Specific Aim 1: Determine
whether a small but distinct myometrial stem cell population serves as pre-fibroid tumor progenitors in AA versus Caucasian
(C) women. Specific Aim 2: Identify PcG/ TrxG (histone methylation regulators) regulated DNA repair target genes that
contribute to developmental reprogramming in UF development. Specific Aim 3: Characterize whether Vitamin D3 is
capable of increasing DNA repair capacity via reversing disrupted epigenetic programming in myometrial stem cells. Impact:
These paradigm shifting concepts will enable us to identify genomic and epigenomic risk profiles associated with increased
susceptibility to UFs in AA women. Such knowledge will inform an efficient precision medicine approach towards the
development of novel preventative and therapeutics strategies for this common health disparity challenge.